Mays Cancer Center at UT Health SA

The Mays Cancer Center (MCC) at the University of Texas Health San Antonio (UT Health SA) is the National Cancer Institute-designated Cancer Center (NCICC) for a 38-county region of Central and South Texas, a region of 45,926 square miles with 4.9 million individuals who have a unique set of cancer-related challenges. The mission of the MCC is to reduce the cancer burden in Central and South Texas through the highest quality cancer care with expanded treatment options from our early phase clinical trials, ground- breaking cancer research aimed at reducing the incidence and mortality of cancer as well as improving treatment options, education of the future leaders of cancer scientists and clinicians, and cancer prevention programs that focus on our unique population. The MCC strives to be the institution of choice for cancer care in South Texas, a highly-productive research institution that attracts and retains the best cancer scientists, is the institution of choice for cancer education, and an organization devoted to reducing the burden of cancer in our region.
Our goal is for the MCC to be a national resource where personalized clinical care and scientific discovery will be conducted, focusing on our South Texas catchment area.

Public health relevance
The Mays Cancer Center (MCC) at the University of Texas Health San Antonio (UT Health SA) is the National Cancer Institute-designated Cancer Center (NCICC) for a 38-county region of Central and South Texas, a region of 45,926 square miles with 4.9 million individuals who have a unique set of cancer-related challenges. The mission of the MCC is to reduce the cancer burden in Central and South Texas through the highest quality cancer care with expanded treatment options from our early phase clinical trials, ground-breaking cancer research aimed at reducing the incidence and mortality of cancer as well as improving treatment options, education of the future leaders of cancer scientists and clinicians, and cancer prevention programs that focus on our unique catchment area population. The MCC strives to be the institution of choice for cancer care in South Texas, a highly-productive research institution that attracts and retains the best cancer scientists, is the institution of choice for cancer education, and an organization devoted to reducing the burden of cancer in our region. Our goal is for the MCC to be a national resource where clinical care and scientific discovery will be conducted, focusing on the unique aspects of our catchment area of San Antonio and South Texas.